Early Events in Extravillous Trophoblast Cell Differentiation

PROJECT SUMMARY/ABSTRACT
During pregnancy, trophoblast cells from the placenta invade into the uterine spiral arteries and assist with the
remodeling necessary for adequate blood supply to the fetus. Cytotrophoblast, an undifferentiated and
proliferative cell subpopulation, can give rise to extravillous trophoblast (EVT) cells. EVT cells are terminally
differentiated trophoblast cells that invade into and restructure the uterine compartment. Impaired EVT cell
development leads to adverse pregnancy outcomes, including early pregnancy loss, preeclampsia, intrauterine
growth restriction, and preterm birth. Human trophoblast stem (TS) can be captured, maintained in vitro under
specific conditions, and differentiated to ST as well as EVT cells. Regulatory mechanisms underlying human
TS cell self-renewal and early events in the differentiation of EVT cells have largely remained elusive. We have
utilized single cell RNA sequencing (scRNA-seq) to identify cell populations and candidate regulators that arise
during EVT cell differentiation. A transcription factor termed CCAAT/enhancer-binding protein beta (CEBPB)
was identified as a candidate regulator of early events in EVT cell differentiation. CEBPB is expressed in an
intermediate progenitor cell population arising during the early stages of EVT cell differentiation and in a
transitional compartment within EVT cell columns of the first trimester human placenta. Depletion of CEBPB in
human TS cells disrupts EVT cell differentiation. We hypothesize that CEBPB contributes to the regulation
of early events in EVT cell differentiation. To investigate actions of CEBPB on trophoblast cell lineage
development we will deplete CEBPB by using lentiviral-mediated shRNA in human TS cells and will evaluate
EVT cell differentiation with sc-RNAseq (Aim 1). To characterize CEBPB gene regulatory networks defining
EVT cell differentiation we will perform chromatin immunoprecipitation-sequencing (ChIP-seq) and single cell
assay for transposase-accessible chromatin with sequencing (scATAC-seq) at day 3 of EVT cell differentiation
(Aim 2). We will evaluate the bioavailability of CEBPB by investigating upstream transcriptional regulation of
CEBPB and post-translational modification (PTM) of CEBPB (Aim 3). The proposed research plan will provide
me with a body of experimental work necessary for publications and preliminary data for R-series grants. I will
utilize the expertise of the mentoring team as well as resources at the University of Kansas Medical Center for
cultivation of professional development skills. These skills will be improved through trainee mentoring, data
presentation, and scientific writing. During the R00 phase I will develop independence from my mentors by
identifying targets of CEBPB and investigating their contributions to invasive trophoblast cell development.

Public health relevance
PROJECT NARRATIVE Impaired extravillous trophoblast (EVT) cell development leads to early loss of pregnancy, a suboptimal fetal environment, and adverse pregnancy outcomes. Regulatory mechanisms underlying human trophoblast stem cell self-renewal and early events in the differentiation of EVT cells have largely remained elusive. The objective of this proposal is to elucidate the role of CCAAT/enhancer-binding protein beta in early events of EVT cell differentiation.